Genetic and molecular mechanisms of Xbp-1 mediated salivary gland development and differentiation

Project Summary
During embryogenesis and in adult, the delicate balance between proliferation and differentiation of the diverse
cellular populations in the Salivary Gland (SG) must be tightly regulated to ensure normal tissue development
and homeostasis. A better understanding of the regulatory mechanisms driving the cell fate decisions and
lineage choices that anchor salivary gland morphogenesis will help identify pathways that are critical for tissue
regeneration following injury, damage, or during diseased states. Xbp-1, specifically the spliced and
transcriptionally active Xbp-1, isoform, has been implicated in Unfolded Protein Response (UPR), differentiation
and a host of other biologically important cellular processes. Our knowledge of Xbp-1 in context of the SG is
limited to scRNA-seq data showing Xbp-1 to be highly expressed in pro-acinar cells (the precursors to acinar
cells) as well as a previously uncharacterized acinar cell phenotype observed in Xbp-1 null mice. The highly
enriched expression of Xbp-1 in the SG and its association with super-enhancers as revealed by our analysis of
genomic and epigenomics datasets, has led us to hypothesize that Xbp-1 plays an important and molecularly
deterministic role in regulating cellular identity and function in the SG. However, the molecular mechanisms
through which Xbp-1, dictates cell fate decisions and controls specific gene expression programs during SG
development remains unexplored. To address these knowledge gaps, we will utilize conditional Xbp-1 knockout
mouse models and sophisticated genomic/transcriptomic approaches to study three independent areas of
interest. First, we will identify the spatiotemporal expression pattern of Xbp-1 in diverse SG cell types and
measure the relative abundance of unspliced and spliced isoforms through developmental stages and during
adult gland maintenance utilizing immunostainings and qRT-PCR (Aim 1). Second, we will use a conditional
knockout (cKO) mouse model to determine the role of Xbp-1, during SG development and adult homeostasis
(Aim 2). Such studies are necessary as they will identify, for the first time, the in vivo functional role of Xbp-1 in
the SG. Finally, we will perform mechanistic studies to identify critical target genes and pathways that are
governed by Xbp-1 and determine how the loss of Xbp-1 alters the gene expression program of the SG.
Importantly, by implementing scRNA-seq studies, we will evaluate effects of loss of Xbp-1 on cell fate trajectories
specifically during acinar development and maturation (Aim 3). Collectively, these studies will further our
understanding of the Xbp1-dependent transcriptional and cellular networks important for the biological function
of the SG particularly as it pertains to secretory acinar cell differentiation. Advances in our understanding of the
underlying mechanisms driving SG development can provide a paradigm for regeneration, identify potential
therapeutic targets to increase salivary flow in patients suffering from hyposalivation, and better inform therapies
to treat patients with developmental dysfunctions and diseases of the salivary gland.

Public health relevance
Project Narrative The development, differentiation and functional maturation of the salivary gland is a tightly regulated process that requires the coordinated activity of important transcriptional networks and signaling pathways. This application focuses on examining the gene-regulatory mechanisms, and in particular the role of the transcription factor Xbp-1, in directing morphogenesis, cellular identity and fate. Such studies will lead to an improved understanding of the inner workings of the salivary gland and can provide molecular insights into regeneration processes that can help patients with salivary gland dysfunction.